Contractor to develop COMPASS, a device agnostic platform that measures and delivers customizable, evidence-informed rehabilitation services to cancer suvivors using mobile phones tablet

Phase II was initiated for this contract via a contract modification.